Intravenous oxygen for the treatment of cardiac arrest

Project Summary/Abstract
Cardiac arrest affects ~700,000 patients annually in the US, with a survival rate between 10% and 30%, and
survivors often suffering from neurologic injury. Despite advances in resuscitation, maintaining adequate
oxygenation during early resuscitation remains a significant challenge, irrespective of the cause of
cardiac arrest. In asphyxia cardiac arrest (ACA), severe hypoxemia is often refractory to conventional inventions
such as mechanical ventilation. In out-of-hospital cardiac arrest (OHCA), where none-asphyxia cardiac cause is
common, existing ventilation methods such as bag-valve-mask and advanced airway placement are often
ineffective to insufflate the lung during early resuscitation. To address this problem, we have developed a new
gas carrier that allows safe intravenous injection of oxygen (IVO2), based on pH-responsive polymeric
microbubbles (PMBs). PMBs feature a thin polymer shell encasing an oxygen gas core (~5 µm), providing high
oxygen content (50% vol/vol) and storage stability. Designed to dissolve immediately in physiological media via
a pH trigger, PMBs deliver a high volume of oxygen without requiring a diffusion sink (e.g., hyperoxic blood),
thereby minimizing risks of embolism or vascular obstruction. The dissolved PMB shells revert to soluble,
excretable components, reducing long-term side effects. In a realistic swine model of ACA, we demonstrated
that administering very small doses of oxygen via PMBs effectively alleviates severe hypoxemia and significantly
improves neurologically intact survival. We propose IVO2 may be developed as a new oxygen therapy for
early resuscitation of cardiac arrest. The project has 3 specific aims. In Aim-1, we will optimize the molecular
structures of PMBs shell polymer to accelerate their clearance. Tissue deposition presents a main risk for
material toxicity, this study will allow minimize long-term adverse effects of IVO2 gas carriers. In Aim-2, building
on our preliminary data, we will further interrogate how dose and treatment timing may influence physiologic
response and mitochondrial health in rodent ACA models. This knowledge is essential to understanding the
therapeutic efficacy and limits of IVO2 as a transitional treatment for ACA. In Aim-3, we will investigate whether
IVO2 can replace and outperform existing ventilation methods in the early resuscitation of a ventricular fibrillation
OHCA swine model to improve neurologically intact survival. By replacing early ventilation efforts, IVO2 may
rapidly restore normoxia in a more reliable way and offer various physiologic benefits e.g., reducing pulmonary
vascular resistance, allowing care provides to focus on chemist compressions and medication provision. All
these factors contribute to earlier ROCS and neurologically intact survival. If success, the proposed therapy may
transform the current paradigm for the early cardiac arrest resuscitation.

Public health relevance
Project Narrative The goal of this project is to investigate a new treatment for cardiac arrest through the intravenous administration of oxygen gas, packaged into pH-responsive polymeric microbubbles (PMBs). Following injection, PMBs fully dissolve within seconds and oxygenate the blood during cardiopulmonary resuscitation (CPR), providing systemic oxygen to the blood vessels, heart and brain, and enhancing their response to resuscitative measures. In this grant, we will optimize the material structure to improve safety, interrogate the effect of dosing and treatment timing in asphyxial cardiac arrest, and test whether injectable oxygen can outperform existing ventilation methods to improve neurological intact survival in a swine model of non-asphyxial out-of-hospital cardiac arrest.